Regulation of the Dynamic Proteome after Ischemic Injury

ABSTRACT
The premise of this work is based on the accumulated evidence that mitochondrial remodeling takes place in the
stressed heart after ischemic injury, and occurs not only in the area at risk, but also in the remaining viable
myocardium that must now alter its work capacity. We previously discovered that ischemia and reperfusion
resulted in mitophagy and biogenesis regulated at the level of RNA translation. This application will explore this
finding further by examining the dynamic protein composition of the active polysomes in hearts subjected to
ischemic stress. Aim 1 will test the hypothesis that regulatory molecules associate with polysomes during
ischemic stress and, in doing so, select mitochondria-targeted mRNAs for active translation. It will further
determine if miRNAs, or rather the loss of certain miRNAs, also govern this process. Results from this project
will develop a detailed portrait of the newly-synthesized proteins in the setting of recovery from ischemia, using
metabolic labeling with a mass spectrometry-compatible Met analog (azidohomoalanine, AHA) to define the new
protein proteome. Work in Aim 2 will define the relationship between alterations in mitochondrial function and
changes in the metabolome that alter protein acetylation and transcriptional output. Work in this aim will employ
various interventions to perturb glycolysis and oxidative phosphorylation, characterize the metabolome, and
correlate results with specific alterations in protein acetylation and the transcriptome, including both mRNA and
miRNA. Experiments will also be performed to explore perturbations, including a high-fat diet and variations in
mitochondrial haplogroup [using cybrid cells and the mitochondrial nuclear exchange (MNX) mouse lines]. The
multi-omics analysis will require the development of novel bioinformatics tools to identify relationships and control
nodes mediated through changes in metabolite levels. We have already identified a common pathway shared
by pioglitazone and GLP1Ra which increase the NADH/NAD+ ratio, inactivate sirtuins, result in increased protein
acetylation, and lower the expression and activity of miR-33. These studies will reveal the mechanisms governing
translational control of mitochondrial biogenesis, which may lead to the development of new therapeutic tools for
regulating this process in the setting of ischemia/reperfusion injury. The second and third aims will yield a new
understanding of the role that metabolism and mitochondrial output has on transcription, and is expected to
identify metabolites of particular importance in transcriptional regulation that may govern cardiac remodeling.
This project is focused on mechanisms of post-infarction remodeling and will yield a new understanding of the
link between mitochondrial function, metabolic output, and transcriptional regulation in the surviving myocardium
after infarction.

Public health relevance
NARRATIVE This project aims to examine mechanisms that govern the deleterious response of surviving tissue after a heart attack, leading to cardiac enlargement and heart failure. This project will address how the heart creates new mitochondria under ischemic stress, will identify factors participating in new protein synthesis in that context, and will examine how changes in mitochondrial metabolism lead to broad changes in gene expression that can alter cardiac function.